Evaluating Medicaid Postpartum Coverage Extensions through and Equity Lens

Project Summary
Recent policy debates to extend Medicaid postpartum are fueled by the US maternal health crisis: The
US maternal mortality rate is the highest among high-income countries and includes stark racial inequities. Black
people have more than 3X risk of dying from pregnancy related causes than White people. Racial and ethnic
disparities for maternal morbidity are equally glaring. Immigrants, too, face higher rates of maternal morbidity
and perinatal complications. Sustained, continuous access to perinatal health care is critical to maternal health
and health equity, yet ~45% of birthing people with Medicaid and CHIP lose coverage after 60 days. Postpartum
Medicaid extensions are key features of recent policy attempts to address the deplorably high Black maternal
mortality and morbidity rates. However, structural racism shaping US institutions means such policies could
either mitigate or exacerbate inequities. Policymakers need evidence about the impact of postpartum Medicaid
access on maternal health equity to guide design and implementation.
Since March 2020, the Families First Coronavirus Response Act (FFCRA) has conferred a de-facto
Medicaid postpartum coverage extension nationwide, but it is due to expire imminently. Meanwhile, 27 states
have already adopted or are seeking to pass legislation to extend postpartum Medicaid coverage, but their
policy approaches vary in legal basis, eligibility criteria, length of coverage, and immigrant exclusions.
Moreover, states vary in their existing Medicaid eligibility policies prior to the pandemic, which has profoundly
shaped who has remained eligible during the pandemic with uncertain eligibility post-pandemic. Our
overarching objective is to evaluate the impact of postpartum Medicaid policy on maternal health
equity. We propose using an adaptive concurrent mixed-methods design to measure national changes in
postpartum Medicaid enrollment while exploiting differences in two states' policies to examine health care
utilization in greater depth. We focus on two large, diverse states: Texas (TX) has expanded Medicaid to six
months postpartum through a demonstration waiver, while New York (NY) is using the American Rescue Plan
Act to expand Medicaid 12 months postpartum. Using national American Community Survey (ACS) and
Medicaid claims data from TX and NY, our quantitative aims will apply interrupted time series (ITS) and
difference-in-difference (DID) approaches. In our qualitative aim, we will interview postpartum women,
healthcare providers, community-based organizations, and policymakers on the efficacy of postpartum
Medicaid extension implementation, which will inform the analysis approach and enrich our findings.
Our proposal not only fills gaps in targeted research on the impact of postpartum Medicaid access on
maternal health equity, but also shifts the paradigm to focus on the role of structural racism in the design and
implementation of policy and its influence on pregnant people's access to postpartum benefits. Our findings will
be a key resource for policymakers on equitable design and implementation of postpartum Medicaid extension.

Public health relevance
Project Narrative Sustained, continuous access to perinatal insurance is critical to maternal health and health equity, yet under longstanding federal law, pregnancy-related Medicaid coverage is only guaranteed through 60-days postpartum. As a result, estimates suggest ~45% of birthing people with Medicaid and CHIP lose coverage after 60 days; many state legislatures and Medicaid programs have passed or are considering passing legislation to extend coverage, but their policy approaches vary. Our project will evaluate the impacts of postpartum Medicaid policy on maternal health equity using an adaptive concurrent mixed-methods approach, and our findings will provide timely insights for policymakers and stakeholders working to improve maternal health outcomes.